Mechanism and functional consequences of dietary lipids in lineage specification and tumor growth in oncohistone gliomas

PROJECT SUMMARY: Mechanism and functional consequences of dietary lipids in lineage
specification and tumor growth in oncohistone gliomas
Diffuse midline gliomas (DMGs) are the most aggressive brain tumors of childhood. Malignant growth of H3K27M
DMGs is linked to reduced activity of the histone methyltransferase polycomb repressive complex 2 (PRC2) and
diminished H3K27 trimethylation (H3K27me3), a repressive chromatin mark. H3K27M-induced reconfiguration
of chromatin architecture suppresses differentiation of cycling glial progenitor cells in the developing brain. This
is further accompanied by increased PDGFRA signaling supporting the expansion of these progenitor cells.
Nevertheless, the tumor cells retain some latent differentiation potential. We and others have shown that this
potential can be unmasked by treatment with serum or pharmacologic remodeling of chromatin, which drive
differentiation of these tumor cells to more mature glial cell lineages and reduce their tumorigenic potential.
In preliminary studies, we have found that; (i) diet-derived lipids in the form of n3-polyunsaturated fatty acids (n3-
PUFAs) are required for serum-induced differentiation of H3K27 DMGs, and (ii) n3-PUFAs’ effect in this setting
is associated with increased H3K27me3 marks, enrichment of more differentiated glial cell population, and
reduction of cycling glial progenitor cell population. This suggests a previously unappreciated link between these
dietary lipids and epigenetic modulation of cell lineage specification. Against this backdrop, our central
hypothesis is that the PUFA pathway (specifically n3-PUFA) modulates cell fate decisions and epigenetic
programs relevant for H3K27M-mediated gliomagenesis. We test this hypothesis by addressing three
fundamental questions. First, what is the functional role of n3-PUFAs in self-renewal and lineage-specific
differentiation of H3K27M glial progenitors? Aim 1 addresses this question by interrogating the causal link
between n3-PUFAs and H3K27M glioma cell state specification through a combination of loss- and gain-of-
function, nutrient rescue assays, and single-cell transcriptomic to rigorously examine the functional contribution
of these lipids to cell fate. Second, what is the biochemical mechanism whereby n3-PUFAs influence these cell
states? Aim 2 addresses this question by characterizing a mechanistic links between these lipids and the
H3K27M DMG chromatin landscape by examining chromatin accessibility of loci specific for distinct cell lineage,
and by interrogating PRC2 activity and PDGFRA signaling as biochemical targets of n3-PUFAs. Third, do PUFA
enrichment strategies have therapeutic potential in DMGs? Aim 3 addresses this question by testing the anti-
tumor effects of n3-PUFA diets or genetic activation of the PUFA pathway in H3K27M DMG PDX models.
These studies are aligned with PAR-23-051 in that they test n3-PUFAs as dietary variables that mechanistically
link epigenetic modifiers/programs to H3K27M DMG cell fate decisions and tumorigenic potential.

Public health relevance
Project Narrative Brain tumors have surpassed the leukemias as the leading cause of cancer-related death in children. Therapeutic options for pediatric brain cancers have shown little expansion over the past few decades and the prognosis for many tumor types (especially Diffuse Midline Gliomas) remains bleak. The research proposed here will examine the utility of dietary fatty acids in halting the growth of Diffuse Midline Gliomas.